T cell control of MCMV and tissue-localized immune suppression

Abstract: Cytomegalovirus (CMV) is the leading infectious cause of birth defects in the developed world. By
some estimates, approximately 1 in 100 to 1 in 150 children in the United States will be born with congenital
CMV and up to half of these children may have long-term health consequences - including hearing loss, vision
impairment and mental disabilities. The highest risk for transmission to the fetus occurs after primary infection
or reinfection of the mother during pregnancy. Thus, a vaccine to prevent CMV transmission is considered a
highest priority by the Institute of Medicine. Unfortunately, the immune system does a poor job at controlling
CMV in epithelial sites of entry and shedding and it is unknown whether the immune system can regulate
dissemination. Thus, our long-term goal is to define tissue-localized pathways that support or limit viral
dissemination and transmission and the function of CMV-specific T cells in these sites. To address this, we
have used the natural mouse pathogen murine (M)CMV, which closely mimics human (H)CMV infection. Both
HCMV and MCMV are thought to use an oronasal route of entry and we found that MCMV persistently
replicates in the nasal mucosa, a natural site of infection. We hypothesize that tissue-localized mechanisms
contribute to this persistence and have identified novel pathways that are active in the nasal mucosa and
salivary gland (the major site of shedding). Specifically, extracellular adenosine modulated the function of anti-
viral T cells and the potent anti-inflammatory lipids known as Resolvins, which were induced in the nasal
mucosa by MCMV infection, modulated viral titers. However, T cells limited viral titers in the nasal mucosa and
our data suggest that they also restricted dissemination in hematopoietic cells. Thus, the central hypothesis of
this proposal is that T cells are limited in their ability to control of the virus in mucosal tissues by at least 2
tissue-localized pathways, but that resident memory T cells may be able to inhibit CMV replication and limit
viral escape from the mucosal tissue. Specific Aim 1 will test the hypothesis that Resolvins and extracellular
adenosine induced by infection suppress tissue-localized immune responses to support long-term MCMV
persistence in the nasal mucosa and salivary gland. Specific Aim 2 will define the mechanisms used by CD4+
T cells to control viral replication in the nasal mucosa, determine whether T cells confine viral dissemination to
infected hematopoietic cells, and test whether resident memory T cells can restrict MCMV persistence and
dissemination in both resistant and susceptible strains of mice. Together, our studies will provide the first
picture of the interplay between CMV, T cells and tissue environment after nasal infection and fill key gaps in
knowledge about natural CMV infection and persistence in mucosal tissues.

Public health relevance
Narrative: Cytomegalovirus (CMV) is the most common infectious cause of birth defects in the developed world, and therefore a major target for immune interventions that will disrupt viral transmission to new hosts or spread within a host. CMV enters hosts through mucosal barrier tissues, where it avoids rapid immune control by unknown mechanisms and then escapes to distant tissues. The aim of this proposal is to define mechanisms that limit T cell control of CMV in a natural mucosal site of entry and to determine how T cells modulate viral persistence and dissemination to distant tissues.